Neurodegeneration and Neuronal Fluctuations in DLB and AD

Project Summary/Abstract
Dementia with Lewy bodies (DLB) is one of the most common neurodegenerative dementias and one of the
Alzheimer disease related dementias (ADRDs), but much less is known about underlying pathophysiology and
structural brain changes in DLB. DLB is frequently misdiagnosed clinically, most commonly as Alzheimer
disease (AD). Currently, DLB diagnosis can only be confirmed post mortem, and early accurate diagnosis is
critically needed to aid treatment, prognosis and long-term care. Diffusion-weighted MRI (dMRI) and task-
based electroencephalography (EEG) are promising neurodiagnostic modalities for better characterizing DLB
and potentially serving as biomarkers, an unmet need. While EEG monitors neuronal activity, dMRI can assess
white matter pathways and neuronal degeneration in vivo. The primary goal of this K23 study is to characterize
pathophysiologic and microstructural changes occurring in DLB, and advance our understanding of how they
correlate with DLB clinical symptoms. I will investigate the pathophysiologic and microstructural changes
occurring in DLB using a novel dMRI technique (Aim 1), and evaluate neuronal desynchronization in DLB using
task-based quantitative EEG (Aim 2). The proposed research addresses a significant gap in the current
literature on the underlying pathophysiology and brain structural changes associated with clinical
manifestations of DLB.
My long-term career goal is to become an independent clinician investigator and leader in the field of ADRDs,
with a focus on Lewy body dementias. The proposed study builds on MRI research that I completed earlier in
my training and will allow me to expand this into Lewy body dementias. I propose a rigorous training program
with advanced coursework in structural imaging and EEG techniques, biostatistics, research design and
execution, professionalism, leadership, and responsible conduct of research. My primary mentor, Dr. David
Vaillancourt, is a well-established NIH-funded researcher in imaging and EEG techniques. He is an
experienced mentor who has successfully trained many young trainees into independent, NIH-funded
investigators. The University of Florida is an ideal environment for this project, not only for the necessary
laboratories, equipment and supplies needed to complete the proposed studies, but also for the Fixel Institute
as one of the leading Lewy body dementia Research Centers of Excellence. Together, the assembled team
and environment will allow me to conduct mentored research with advanced neurodiagnostic techniques
important for understanding DLB pathophysiology, and improving therapeutics in the future.

Public health relevance
Project Narrative Dementia with Lewy bodies (DLB) is one of the most common neurodegenerative dementias after Alzheimer disease (AD). The proposed study will provide novel insight into the pathophysiological brain changes in individuals with DLB, compared to AD and healthy older adults, using diffusion-weighted MRI (dMRI) and task- based high-density electroencephalography (EEG). This research has the potential to inform future development of dMRI and EEG as potential biomarkers for DLB, to examine longitudinal progression of disease, and determine whether therapeutic interventions are having expected effect(s) on brain microstructure and cortical activity.